Core B - Retrotransposon Genomics, Technology and Analysis Core

Core Summary
Core B will provide cutting edge tools to measure retrotransposition in
multicellular eukaryotes in the context of aging paradigms with a special focus on
Alzheimer’s disease and related disorders. In addition to providing appropriate
existing assays and mouse models to all of the participants, the core will also
develop improved retrotransposition reporters and genomics tools to enable the
detection and mapping of retrotransposition events in the various experimental
systems under study. The Core will also provide “Driver systems” that lead to
high level expression of these elements in both cell systems and animals. Finally,
the core will provide cutting edge sequencing and computational tools to analyze
both retrotransposition itself and the aberrant forms of LINE-1 expression and
reverse transcription observed in aging cells and organisms.